Regulation of Voltage-gated Proton Channel

Abstract
The voltage-gated Hv1 proton channel is a member of voltage-gated ion channel family, it
plays a key role in the acid extrusion from excitable and non-excitable cells and regulate pH
homeostasis in a variety of cell types. The Hv1 proton channel provides charge and pH
compensation during the respiratory burst of the phagocyte NADPH oxidase and controls
production of reactive oxygen species in phagocytes, it mediates proton efflux at the pulmonary
alveolar cell membrane and acidifies excessively alkaline airway surface liquid in the airway cells.
Hv1 is found to be a sperm flagellar regulator of intracellular pH, and play a crucial role in sperm
capacitation. In addition, Hv1 activity is required for acid extrusion to shape action potentials in
snail neurons. Studies have shown that biophysical properties and functions of the Hv1 channel
are not identical in a variety of tissues, the distinct manifestations of native voltage-gated proton
channels in different cell types indicate the existence of modulatory partners modulating the Hv1
proton channel's function. We recently identified a family of transmembrane protein as the Hv1
channel interactor. We discovered that the presence of the transmembrane protein alters the Hv1
channel's activity and modulates the channel's voltage-dependent gating. The goal of this
proposal is designed to determine the effects of the transmembrane protein on the Hv1 channel
physiology, biophysics, and pharmacology. The proposed research will establish the physiological
relevance of Hv1 channel regulation by transmembrane modulators and shed light on novel
voltage-gated ion channel regulatory mechanisms.

Public health relevance
PROJECT NARRATIVE The voltage-gated proton channel Hv1 plays roles in proton extrusion, pH homeostasis, and production of reactive oxygen species in a variety of cell types. There is a need for discovery of Hv1 regulators that confer important physiological profiles required for the function of cells where the Hv1 channels expressed. We identified new Hv1 channel regulators and will determine the roles of their function in regulation of Hv1 proton channel.